Targeting DNA Ligase I in Ovarian Cancer

PROJECT ABSTRACT
Abnormalities in genome maintenance pathways offer an opportunity to develop therapeutic approaches that
selectively target cancer cells. Furthermore, because of their proliferative nature, cancer cells are susceptible
to replication-associated DNA damage and more dependent upon the pathways that deal with this type of
damage. In a recent collaborative study, we found that the levels of DNA ligase I (LigI), the major enzyme joining
Okazaki fragments at the replication fork, correlates with outcome and therapy resistance in ovarian cancer.
Further, we found that ovarian cancer cells, which have a defect in homology-dependent repair (HDR), are
sensitive to LigI inhibition. In preliminary studies we compared the effects of LIG1 deletion with chemical
inhibition. In LIG1 null cells, there were elevated levels of XRCC1, the partner protein of LigIII, and PARP2
associated with newly synthesized DNA, consistent with the PARP- and LigIII-dependent back-up pathway that
joins Okazaki fragments and enables cells to replicated in the absence of LigI. In contrast, incubation with the
LigI inhibitor did not result in increased levels of XRCC1 or PARP2. Instead, there were elevated levels of the
Mre11Rad50Nbs1 complex, that initiates the resection step of homology-dependent repair (HDR). In aim 1, we
will use a combination of genetic, cell biological and biochemical approaches to determine the mechanism of the
HDR pathway induced by LigI inhibition. Since HDR deficiency occurs in both inherited and sporadic forms of
ovarian cancer and we have identified LIG1 as a biomarker of outcome and therapy resistance in ovarian cancer,
we will examine the activity of the LigI inhibitor alone and in combination with DNA repair inhibitors and/or
genotoxic chemotherapeutics in genetically-defined ovarian cancer cell lines. Building upon our existing LigI
inhibitors in aim 2, we will use a combination of molecular modeling and medicinal chemistry to design and
synthesize putative LigI inhibitors that are predicted to have enhanced potency and selectivity as well as
improved pharmacological properties. The activity of the putative LigI inhibitors will be evaluated in parallel
biochemical assays with purified human DNA ligases and cell-based assays with genetically-defined ovarian
cancer cell lines. In aim 3, we will first examine the activity of existing and new LigI inhibitors for activity in
genetically-characterized patient-derived organoids alone and in combination with DNA repair inhibitors and
chemotherapeutics used to treat ovarian cancer. Subsequently, combinations with the highest activity will
evaluated in mouse xenograft models of ovarian, including patient-derived xenografts. Together, the proposed
studies will provide mechanistic insights into replication-associated PARP-dependent and HDR pathways that
are critical in LigI deficient cells, develop improved LigI inhibitors and identify specific DNA alterations that confer
sensitivity to the LigI inhibitor alone or in combination with DNA damaging agents and/or DNA repair inhibitors
in preclinical ovarian cancer models, providing the rationale for the further development of LigI inhibitors as a
novel therapeutic for ovarian cancer.

Public health relevance
PROJECT NARRATIVE Among the gynecological cancers, patients with ovarian cancer have the worst outcomes, indicating the need for new and improved treatments. Our published work has shown that high levels of DNA ligase I, a key DNA replication enzyme, correlate with poor outcomes and resistance to chemotherapy in ovarian cancer, and that specific forms of ovarian cancer are sensitive to a DNA ligase I inhibitor. We expect that the results of this grant will identify DNA ligase I as a valid target for development as a drug that will be used to improve outcomes for patients with ovarian cancer.